Texas Laboratory Flexible Funding Model: Enhancing the Capacity and Capability of Human Food and Environmental Testing

Enhancing the Capacity and Capability of Human Food and Environmental
Testing at the Texas Department of State Health Services
Project Summary
The Texas Department of State Health Services (DSHS) Public Health Laboratory Division
(PHLD) works in conjunction with the Food and Drug Administration (FDA), the Centers for
Disease Control and Prevention (CDC), and the state regulatory body, DSHS Consumer
Protection Division (CPD), to ensure food and food products in Texas are safe. As a part of an
integrated food safety system, the goals of the PHLD are to facilitate and improve food testing
surveillance, inspection, and investigation in the State of Texas.
With the funding provided by this grant, CPD will continue partnership with PHLD by acting as
the PHLD sampling organization. As part of the official sampling plan, PHLD will test
approximately 500 samples annually under the Microbiology Human Food Product Testing track
and 400 samples annually for the Microbiology Whole Genome Sequencing Track. The PHLD
has the capability to test human food and environmental samples for the presence of
Salmonella, Shiga-Toxin producing Escherichia coli (STEC), and Listeria; and consistently
tested a high volume of samples for these pathogens during the previous grant cycle (2020 to
2025). The Genetic Sequencing Branch (GSB) serves as the core facility for Next Generation
Sequencing (NGS) and Whole Genome Sequencing (WGS) for the PHLD, and works closely
with the PHLD’s Consumer Microbiology Group (CMG) and Clinical Bacteriology Group (CBG)
to obtain enteric pathogens from routine and surveillance food and environmental sample
testing. The PHLD also receives food and environmental samples from the University of
Houston at Clear Lake and Texas A&M University.
The Public Health Laboratory Division (PHLD) is also the primary servicing laboratory for the
state Manufactured Foods Regulatory Program (MFRP) for radiochemistry testing. The
Radiochemistry Group within the Environmental Chemistry Unit at the PHLD has been receiving
human food samples collected by MFRP since 2016 as part of the FDA Rad CAP Safety and
Defense Routine Monitoring project. A total of fifty (50) samples are collected by the MFRP
annually and submitted to the PHLD for gamma emitting radioisotopes. The PHLD has
previously participated in the Radiochemistry Food Defense track, and in this grant cycle seeks
to add the Chemistry Food Defense track, as well as the associated Chemistry MDV and C/C
tracks. The Inorganic Chemistry Group, also within the Environmental Chemistry unit, has
participated in FERN proficiency testing exercises and has trained staff and instruments
necessary to carry out both LC-MS and GC-MS testing.

Public health relevance
Enhancing the Capacity and Capability of Human Food and Environmental Testing at the Texas Department of State Health Services Project Narrative With this funding opportunity, the Texas Department of State Health Services (DSHS) Public Health Laboratory Division (PHLD) intends to use funds to maintain and build our capabilities and capacity for microbiological, radiochemistry and chemistry based food testing and emergency response to improve the overall national safety of our food supply and public health. Texas DSHS seeks to continue participation in Microbiology and Radiochemistry project tracks, and to add new inorganic testing via the Chemistry – Food Defense track. In addition to improving DSHS ability to monitor and respond to food supply threats, this cooperative agreement will enhance collaborations with our federal partners and improve data exchange.